UNC-CH Training Program in Health Services Research

Project Summary/Abstract
The Cecil G Sheps Center at The University of North Carolina at Chapel Hill requests a competing renewal for
our pre and post-doctoral interdisciplinary training program in health services research for the years 2018-23.
Predoctoral trainees will be supported by the program for two years, and will have already completed their
coursework. They will be drawn from multiple disciplines including: health policy, epidemiology, health
behavior, economics, pharmacy, allied health, nursing, and sociology. Post-doctoral trainees will work with a
mentor to develop and complete research related to the delivery of health services in the currently changing
health care system. While some post-doctoral trainees may have had PhD level training, others will be MD,
PharmD, or DDS clinicians who complete a master's degree in public health during the fellowship. Many
trainees will collaborate with investigators at the Sheps Center on projects funded by the Agency for
Healthcare Research and Quality, National Institutes of Health, Health Resources and Services Administration,
the Patient Centered Outcomes Research Institute, and others. All trainees participate in a weekly, two-hour
interdisciplinary seminar during which work in progress sessions monitor their development, as well as
participate in discussions of methods issues in health services and patient-centered outcomes research, as
well as career development activities. Mentoring in the fellowship is provided by an interdisciplinary faculty, led
by the program director, Mark Holmes, PhD, director of the Sheps Center and an economist and health
services researcher. He will be supported by six interdisciplinary faculty who are accomplished mentors and
researchers: Kathleen Thomas PhD (mental health services research), Tim Carey MD MPH, (general internal
medicine and comparative effectiveness research), Barbara Mark RN PhD (nursing and care quality), Betsy
Sleath PhD (Pharmaceutical Policy), Til Stürmer MD PhD (Epidemiology) and Morris Weinberger PhD
(Sociology and Health Policy). Fellows will also have access to the facilities and resources of the Sheps
Center for Health Services Research, a pan-university center currently conducting over 60 projects with an
annual budget of over $18M per year, as well as the broader resources of the University of North Carolina at
Chapel Hill. We are requesting funding for 4 pre and 4 post-doctoral fellows per year. All trainees receive
training in the responsible conduct of research specific to health services research. We make particular efforts
to attract and train minority trainees. We will build on our experience since 1989 of training fellows who
advance to successful careers in academic research, state and local government, health care delivery
systems, and the private sector.

Public health relevance
Project Narrative The US health care system is rapidly transforming in response to social, economic and policy changes and requires timely research designed to be informative to and actionable by health care professionals, delivery systems, policymakers, and the public. Skilled researchers are needed to assist in these changes so as to maximize the quality and efficiency of clinical care, and to address current disparities in health and health care. We propose to train PhD and clinical investigators in the methods of health services research toward those goals.